Impacts of Benzo[a]pyrene on Microbiome Development across Lifespan and Generations and the Behavioral Consequences

PROJECT SUMMARY/ABSTRACT
This supplement grant application aims to support the professional development of a Black, female, veteran
graduate student who is pursuing a career as a toxicology research scientist. To accomplish this goal, the
candidate’s co-mentors – Dr. Thomas Sharpton and Dr. Robyn Tanguay – have worked with the candidate to
develop a research, training, and mentorship plan that will ensure the candidate’s professional success. This
plan includes an extensive interdisciplinary training program that incorporates both didactic and experiential
learning modalities, as well as a personalized, intimate, and supportive mentorship program. Additionally, the
plan includes an interdisciplinary and cutting-edge research project that will help the candidate catapult their
career forward. In particular, the candidate will conduct research that extends the R01 parent award into
complimentary, but new areas. Briefly, the parent award focuses on defining how early life exposure to
pollutants impacts assembly of the gut microbiome to impair behavior development, and focuses specifically on
benzo[a]pyrene as a model pollutant. As part of this supplement grant, the candidate will apply the tools and
technologies developed under the parent award to investigate a specific class of environmental chemicals of
concern, namely a diverse array of per- and polyfluoroalkyl substances (PFAS) that have been shown to impair
behavior development in vertebrates. In so doing, the candidate will resolve how embryonic exposure to
various PFAS impacts gut microbiome assembly and whether these alterations to the gut microbiome mediate
how PFAS impair behavior. As a result, the candidate will obtain interdisciplinary experience in an emerging
area of toxicology, especially with respect to bioinformatic and data science approaches, and will clarify
potential mechanisms through which PFAS elicit their effect on vertebrate behavior. In total, the proposed plan
will equip a passionate junior scientist from an underrepresented community to thrive in the competitive
research landscape.

Public health relevance
PROJECT NARRATIVE This supplement grant application seeks to improve the representation of individuals from diverse backgrounds in the toxicological sciences by supporting the professional development of a Black, female, veteran. The candidate of the application will lead a high-impact, interdisciplinary research project that seeks to define whether the gut microbiome mediates how per- and polyfluoroalkyl substances (PFAS) impair behavior development in juveniles. This research plan naturally extends from the parent R01 award and is complimented by an extensive training and mentorship program.